Genetic Mouse Core

The Mouse Genetic Core (Core A) is an integral part of this effort, as it has in the past and hopefully in the future will support the work ofthe Program Project Grant by providing complex knockout mice and BAC transgenic mouse strains will serve as a repository for all newly developed mouse strains. Core A has three Specific Aims: #1 To generate novel knockout mouse strains, which will support P#1 and P#2 and based upon interactions with human studies in P#2 and P#3. #2 To generate transgenic mice based BAC clones and mutant BAC clones obtained by multi-step recombineering, which will support P#1 and P#2 and based upon interactions with human studies in P#2 and P#3. #3 To support the mutant mouse activities in P#1 and P#2, and to maintain the transgenic and knockout mouse strains used by P#1, P#2 and to facilitate treatment studies as guided by P#3. .

Public health relevance
Results of these studies should lead to 1) better diagnostic tools to complement currently used indexes, 2) reliable and specific biomarkers to monitor and hopefully predict disease activity and 3) novel treatment protocols for SLE patients to replace or add to immunosuppressive drugs